Non-perturbative imaging of intracellular drug exposure and drug response of kinase inhibitors

Abstract:
The past two decades have witnessed unparalleled success in the development of therapeutic kinase inhibitors
targeting protein enzymes that are essential for cellular signaling cascades. The major challenges in kinase
inhibitor drug treatment are interindividual variability, compromised drug efficacy, inevitable drug resistance, and
toxicity. All of these properties depend strongly on intracellular drug concentration, which can be profoundly
influenced by heterogeneous tissue penetration, drug transport, and lysosomal drug sequestration. However,
currently there is no technology that can quantitatively examine intracellular concentration of kinase inhibitor
drugs in living cells with subcellular spatial resolution. Stimulated Raman scattering (SRS) microscopy is an
emerging chemical imaging technique that monitors molecule-specific vibrational signatures to provide
quantitative, spatially resolved measurements of molecular concentration. We propose to develop novel SRS-
based methods to enable non-perturbative, quantitative determination of single cell drug exposure for the first
time. The first method uses the pH partition theory to derive cytosolic drug concentration based on lysosomal
drug sequestration of weakly basic drugs. The second method uses an ultrasensitive Fourier-transform SRS
technique and advanced chemometric analysis to directly determine cytosolic drug concentration. We will use
these innovative methods to determine EGFR inhibitor penetration and drug sequestration in vitro using 3D
tumor spheroids and in vivo using the dorsal skinfold chamber mouse model. In addition, we will systematically
vary the physicochemical properties of drug compounds and determine their influence on drug transport,
sequestration, and penetration. The second goal of this proposal is to elucidate the heterogeneity of cell response
to kinase inhibitor drug treatment. Drug response of cancer cells depend on not only their genetic aberrations,
but also their phenotypic states and microenvironments. Traditional proliferation assays measure the ensemble
response of a cell population and are unable to resolve the highly heterogeneous drug response of cells in a 3D
environment. We propose to develop a quantitative, high sensitivity single-cell growth-rate measurement
technique based on deuterium pulse labeling. We will validate the use of growth rate change as an accurate
predictor of drug response. By combining single cell drug exposure and drug response measurements in 3D
tumor spheroids, we will further dissect the influence of drug penetration, intracellular drug exposure, and cell
microenvironment on cell drug response. The proposed work builds on our strong expertise in label-free optical
imaging and addresses key challenges in drug discovery and development by providing unprecedented
measurement capabilities. The technologies and methods developed can be broadly applied to small molecule
drugs, with great potentials to accelerate early stage drug discovery and empower personalized drug screening.

Public health relevance
Public Health Relevance/Narrative Small molecule kinase inhibitors have played an increasingly prominent role in treating many diseases including cancer. This project aims to develop innovative technologies and methods to quantitatively measure single cell drug exposure and drug response of kinase inhibitors. These unprecedented measurement capabilities will improve understanding of the origin of drug resistance, provide key data for accurate modeling of single cell pharmacokinetics, and accelerate early stage drug discovery.